Public Health and Autism Science advancing Effectual Strategies across the life course (PHASES)

Modified Project Summary/Abstract Section

Autism is a common neurodevelopmental condition that affects functioning and well-being in a myriad of domains across the life course. The proposed Autism Center of Excellence, “Public Health and Autism Science advancing Effectual Strategies across the life course” (PHASES) application proposes to employ an overarching public health research framework to examine health determinants, health differences, and health services delivery and their impact on health outcomes. Projects in our center highlight different stages of the life course – early childhood, adolescence to young adulthood, and older adults. Project 1 addresses predictors of age of diagnosis among young children with autism, with emphasis on variation in access to universal, high-fidelity screening during primary care visits, with a goal of ensuring access to early detection for all. Projects 2 and 3 examine Medicaid claims and other national data to address key issues arising from the disproportionate burden of co-occurring health conditions in autistic adolescents and young adults (Project 2) and middle age-to-older adults (Project 3). Each of the 3 studies targets unique groups characterized by potentially modifiable adverse outcomes: young children with delayed autism detection, autistic adolescents and young adults with co-occurring conditions, older autistic adults with co-occurring health and cognitive deterioration. The three Center Aims address the following research goals at three different key life stages: Aim 1 investigates modifiable health determinants for autistic individuals; Aim 2 evaluates variation in health and health services in persons on the autism spectrum; and Aim 3 examines the relations between health services delivery and health outcomes. The Center will be supported by three cores facilitating synergy across projects: the Administrative Core streamlines communication and collaboration across projects; the Dissemination and Outreach Core facilitates engagement with stakeholders and expands our existing activities to emphasize bidirectional communication between our team and the community; and the Data Core ensures quality, integrity, and security of data from large sources (e.g. Medicaid, Medicare, electronic health records). Overall, the Center will address preventable adverse outcomes and promote wellbeing in individuals on the autism spectrum, with a focus on several priorities identified by the Interagency Autism Coordinating Committee, including research across the lifespan and improving health outcomes for all autistic persons.

Public health relevance
Modified Public Health Relevance Section Autistic persons experience health challenges throughout the life course, which result in preventable adverse outcomes disproportionally affecting autistic individuals. The Public Health and Autism Science advancing Effectual Strategies across the life course (PHASES) Center uses an integrated public health research framework to characterize and mitigate health differences in persons on the autism spectrum.